INVESTIGATOR DEVELOPMENT CORE

PROJECT SUMMARY – INVESTIGATOR DEVELOPMENT CORE
The primary goal of the Investigator Development Core (IDC) is to support the career development of post-
doctoral fellows, junior faculty, and early-stage investigators in the area of prostate cancer research. In addition,
the objectives of the IDC are to engage researchers across disciplines to promote interdisciplinary collaborations
and address prostate cancer disparities from biological and social perspectives. The Center for Cancer Research
and Therapeutic Development faculty members have complementary and integrated expertise and
demonstrated an ongoing record of accomplishments in prostate cancer research. The program will support two
pilot projects each year from a strong pipeline of pilot project applications with a potential pool of twenty
prospective investigators who require funding to generate data for application to external granting agencies. A
scientific committee will evaluate the pilot project proposals through a peer-review process before funding the
projects. Also, the project-specific committee will provide mentoring support to pilot project recipients to promote
their projects’ success. The proposed pilot projects are consistent with the NIH’s Roadmap for Medical Research,
which acknowledges integrating behavioral and social science research with biological research in addressing
health disparities. The proposed activities will strongly support the career development and enhancement of the
competitiveness of diverse investigators, particularly early-stage investigators, in basic biomedical and
behavioral sciences. In addition, the proposed plan for soliciting and evaluating research proposals, prioritizing
projects, and monitoring their performance in achieving project goals will further enhance the investigator
development and research capacity at Clark Atlantan University.